A Point-Scanning Confocal Microscope for the Biomedical Sciences

PROJECT SUMMARY
In 2009, the University of Wisconsin (UW) was awarded an NIH Shared Instrumentation Grant to establish
a confocal microscope in an imaging core facility. The core acquired a Nikon A1R confocal microscopy system
and began immediately offering investigators from across the campus the opportunity to incorporate confocal
imaging in their research. Here we request funds for a direct replacement of this 13-year-old instrument with a
Nikon AX R confocal microscopy system equipped with both galvanometer and resonance scanners, four laser
lines, spectral and high-sensitivity GaAsP detectors, autofocus and incubation systems for 4D time-lapse
imaging, and Nikon Elements software. This instrument will be housed at the University of Wisconsin Optical
Imaging Core (UWOIC) facility, where the A1R instrument has served 275 users from 90 laboratories in 31
departments across 5 schools. The UWOIC facility is well-supported institutionally by the UW School of Medicine
and Public Health (UWSMPH) to provide access to a range of optical imaging modalities to all research groups
on campus, with an emphasis on high speed, high-resolution microscopy. Importantly, UWSMPH has outfitted
our core facility with a full tissue culture suite, with space for animal housing available on a nearby floor, to enable
users from anywhere on campus to use instruments here. Funds committed to this application from the
UWSMPH Dean’s office will provide salary support for the full-time UWOIC facility manager and greatly extend
the service contract and therefore the lifetime of this new instrument. UWSMPH funded multiple software and
hardware upgrades to the current A1R confocal to extend the warranty, but after 13 years Nikon considers this
instrument obsolete and made the decision not to allow further extensions. Age, poor stability, and outdated and
end of life optical and electrical components motivate the immediate acquisition of a new instrument.
In selecting this replacement, microscopes from Leica Microsystems (Stellaris), Olympus (FV3000), Zeiss
(LSM 980 Airyscan 2), and Nikon (AX R) were evaluated to determine which instrument would be the best suited
for operation in our multi-user imaging facility. After comparing each of the systems mentioned and reviewing
their reliability and service records, we concluded that the Nikon AX R offers the best balance of flexibility in
scanning and detection capabilities, highest field of view, best software interface, and live-cell imaging
performance needed to serve investigators with a wide range of research projects and experience. Each
component of this system is well justified by the needs of more than 20 users that exemplify the depth and
breadth of the research requiring confocal microscopy at our facility.

Public health relevance
PROJECT NARRATIVE The University of Wisconsin Optical Imaging Core (UWOIC) is the flagship service microscopy core of the UW-Madison School of Medicine and Public Health, and currently houses six microscopes for high-speed and high-resolution biological imaging. The purpose of this application is to replace a heavily utilized inverted laser-scanning confocal microscope that was purchased 13 years ago with a funded NIH S10 award. Replacement of this instrument with a modern and well-maintained instrument will ensure the continued success of >20 NIH-funded investigators at UW-Madison that currently depend on a service core confocal microscope for their NIH funded research.